ARSENIC TRIOXIDE IN HORMONE REFRACTORY PROSTATE CANCER

Prostate cancer is the most common malignancy and second cause of cancer death in males in the United States. In most cases, death results within about 1 year from progression to hormone-refractory (HRPC) metastatic disease, which is often attended by severe bone pain due to metastasis. No form of post-hormonal manipulative therapy has yet been definitively demonstrated to prolong survival. Exploratory treatment approaches are highly justified to attempt to identify more effective agents. This is a single-arm Phase II study to evaluate the response rate of patients with metastatic (M1/D1-2 disease) hormone refractory prostate cancer to intravenous arsenic trioxide therapy. This is a collaborative study between the Montefiore Medical Center, Bronx, New York and the Mount Sinai Medical Center, New York, New York. It will have a standard two-stage accrual design for early termination in the event of insufficient ageny efficacy.